Investigating mechanisms controlling tissue-level coordination of Planar Cell Polarity

PROJECT SUMMARY
Cells are collectively oriented along tissue axes to execute coordinated behaviors during embryonic
development. The highly conserved Planar Cell Polarity (PCP) pathway allows cells to communicate directional
information with each other to direct essential processes such as neural tube closure, axis elongation, and
heart morphogenesis. The core PCP pathway includes three transmembrane proteins (Celsr1, Fzd6, and
Vangl2), which form complexes on opposite sides of the cell. Through interactions with intracellular binding
partners, these proteins are able to self-organize such that Vangl2/Celsr1 complexes enrich on one side while
Fzd6/Celsr1 complexes enrich on the other side of the cell. Extracellularly, Vangl2/Celsr1 complexes form an
asymmetric junction with Fzd6/Celsr1 complexes to directly link PCP asymmetry between neighboring cells. A
defining characteristic of PCP organization is its alignment with a tissue axis which allows cells to uniformly
orient PCP asymmetry across great distances. This stereotypic pattern cannot be achieved by
self-organization alone as cells could spontaneously organize in any orientation with respect to the tissue axis.
For this reason, a well-accepted hypothesis emerged that a ‘directional cue’ acts in a gradient across a tissue
to bias the distribution of PCP proteins along the same axis. Currently, the identity of potential ‘directional cues’
remain elusive, and how the core PCP pathway interacts with the cue to generate tissue-level asymmetry is
unknown. Forward genetic screens are a powerful tool to identify genes involved in a particular process based
on the phenotype. In fact, core PCP genes were identified in Drosophila based on disrupted bristle orientations
in the wing and thorax of PCP mutants. However, the same approach is less successful in identifying genes
that encode ‘directional cues’ as they are also thought to be essential for the development of the tissue itself.
Fortunately, breeders have performed their own forward genetic screen in guinea pigs and mice, selecting for
naturally occurring genetic variants with altered hair follicle orientation. Similar to Drosophila bristles,
mammalian hair follicles are oriented by the PCP pathway. The altered fur orientation in these natural variants
shows that planar polarity alignment is decoupled from the body axis in a region-specific and uniform manner,
suggesting the causative mutations alter ‘directional cues.’ Remarkably, the viability of the animals and the
overall architecture of the skin itself remain unaltered. By turning to these natural variants, I hypothesize that I
will be able to identify ‘directional cues’ that link PCP asymmetry to a tissue axis. By computationally mapping
the genetic variants, I will reveal genes required to link PCP alignment to a tissue axis. Through phenotypic
characterization in vivo and in vitro, I will define how the altered gene impacts PCP asymmetry at individual
junctions and its alignment across the entire tissue. This research will uncover mechanisms coordinating cell
behaviors across tissues, lending insight into a fundamental process that is required for proper development.

Public health relevance
PROJECT NARRATIVE Over the course of development, the Planar Cell Polarity (PCP) pathway coordinates cell behaviors across a tissue or body axis to direct collective cell movements required for neural tube closure and axis elongation. Currently, the mechanisms that align PCP activity with a body axis remain unknown. Because hair follicle orientation is controlled by the PCP pathway, we can utilize natural genetic variants that decouple hair follicle orientation from the body axis to understand how PCP activity is aligned with a tissue axis, revealing a fundamental principle required for embryonic development.